Mechanism of pulmonary vascular wall thickening in COVID-19

Summary/Abstract
Currently the world is suffering from the pandemics of coronavirus disease 2019 (COVID-19), caused
by severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) that uses angiotensin-converting
enzyme 2 (ACE2) as a receptor to enter host cells. So far, over five million people have been infected with
SARS-CoV-2 and over 300,000 people have died of COVID-19 worldwide, causing serious health,
economical, and sociological problems. The aging population with cardiovascular comorbidities is highly
susceptible to be severely affected by and die of COVID-19. However, the mechanism underlying this
increased susceptibility has not been defined. Lack of such knowledge interferes with the development of
therapeutic strategies to prevent death by COVID-19. The long-term objective of our research is to define
the pathogenic mechanism of the SARS-CoV-2 infection to identify new therapeutic targets to combat
COVID-19. We recently identified the occurrence of pulmonary vascular wall thickening in patients
infected with SARS-CoV-2 who died of COVID-19, but not in patients infected with SARS-CoV-1 or
influenza virus. In this project, we will test the central hypothesis that the SARS-CoV-2 spike protein
promotes cell growth signaling in lung vascular smooth muscle cells. This hypothesis is based on
preliminary results obtained in my laboratory showing that (i) the treatment with recombinant SARS-CoV-2
spike protein (without the rest of viral components) strongly activates cell growth signaling (the activation
of mitogen-activated protein kinase) in human pulmonary artery smooth muscle cells; (ii) the ACE2
receptor binding domain of SARS-CoV-2 spike protein alone is not sufficient to activate cell growth
signaling; and (iii) SARS-CoV-2 spike protein increases the protein expression of ACE2. We plan to
accomplish the objective by addressing the following specific aims: (1) Establish the uniformity of
pulmonary vascular wall thickening in patients who died of COVID-19; (2) Determine the mechanism of
SARS-CoV-2 spike protein-mediated cell signaling in pulmonary artery smooth muscle cells; and (3)
Define the role of SARS-CoV-2 spike protein-mediated cell signaling in the COVID-19 pathology. This
project is innovative because it will address a novel mechanism of the SARS-CoV-2 infection and
pathogenesis and the role of pulmonary vasculatures in the pathology of COVID-19. Results of this project
are significant because they are expected to contribute to the development of new therapeutic agents to
reduce the death caused by COVID-19 that occurs largely in the aging population.

Public health relevance
Project Narrative Currently, the world is suffering from the pandemic of coronavirus disease 2019 (COVID-19) that is caused by a virus called severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), killing many people, especially elderlies. Because our initial observations noted that lung blood vessel walls are thickened in patients who died of COVID-19, this project will further examine patient specimens to define if lung blood vessel walls get thickened in COVID-19 and provide information pertaining to how this may occur. The successful completion of this project should provide invaluable information that leads to the development of therapeutic strategies to combat this pandemic and save lives of many people, especially the elderly.